ADMINISTRATIVE CORE

The principal decision-making unit for the Program Project will be the Administrative Core. The performance, effectiveness, and objectives of this core will be evaluated during regularly scheduled meetings of the project and core directors (i.e., the Director's Board). The specific aims of the Administrative Core are: A. Project Integration and Planning This core will optimize communication between the projects and their associated teams in order to help integrate their research efforts to assure that collaborative studies are conducted efficiently and interpreted appropriately and findings are disseminated throughout the group. The Administrative Core will participate in both short- and long-term planning for the projects to assure that objectives are achieved. B. Scientific Oversight The Administrative Core will routinely assess the progress of each project in order to maintain quality control, to assure optimal integration and to provide overall direction. This will be achieved through regularly schedule meetings at all levels of the Program Project and formalized biannual progress report processes. C. Administrative Support The Administrative Core will provide administrative support for the projects by assuming budgetary responsibility for purchasing research and office supplies and working with the Animal Core to manage and maintain laboratory animals and facilities. In addition, the Administrative Core will manage salary and payroll affairs for all members of the Program. Finally, the Administrative Core will oversee the preparation and submission of annual reports to NIDA and the University of Utah for noncompeting and competing renewals as well as serve as the principal contact for communication with NIDA or other agencies concerning theses projects.